Alveolar Epithelial Cell Dysfunction in Pulmonary Fibrosis: Leveraging SFTPC Mutations for Discovery of Molecular and Cellular Targets

ABSTRACT
Idiopathic Pulmonary fibrosis (IPF) is a devastating interstitial lung disease (ILD) of older adults characterized
by disruption of distal lung architecture that ultimately leads to scar formation, abnormal gas exchange, and
respiratory failure. Key barriers to better IPF outcomes have included an incomplete understanding of its
pathophysiologic underpinnings and a dearth of translationally relevant preclinical models. However,
identification of rare genetic variants in the alveolar epithelial type 2 (AT2) cell-restricted Surfactant Protein C
(SP-C) gene (SFTPC) in subsets of PF patients has been part of a paradigm shift in which dysfunctional AT2
cells serve as a proximal driver of IPF. Coupled with the recent identification of a population of “reprogrammed”
AT2 cells in human IPF lungs deficient in classic AT2 transcriptional programs and enriched in profibrotic
mediators, new opportunities are emerging for therapeutic discovery for IPF. Our prior in vitro modeling
demonstrated that IPF-associated SFTPC mutations produce aberrant SP-C proprotein isoforms that
functionally disrupt epithelial cell quality control (QC) yielding 2 phenotypes: “ER stressed” from misfolding
(“BRICHOS”) mutant with activation of all 3 signaling arms (ATF6, IRE1, PERK) of the unfolded protein
response (UPR) or impaired autophagy / mitophagy secondary to proSP-C mistrafficking (“Non-BRICHOS”)
mutants. The prior funding period provided in vivo proof of concept for a seminal role for disrupted AT2 QC
showing that expression of either non-BRICHOS (SftpcI73T) or BRICHOS (SftpcC121G) mutants in mouse lung
epithelia are each sufficient to evoke a spontaneous fibrotic lung phenotype with recapitulation of many
consensus IPF defining elements. Further, we also published that SftpcC121G mice develop marked activation
of the AT2 UPR with emergence of a reprogrammed transition state. Our Preliminary Data will show that
mutant Sftpc expression in mice can also cause AT2 glycolytic reprogramming and altered mitochondrial
dynamics (biogenesis, fission, and respiration) along with emergence of the aberrant alveolar epithelial cell
transition state. Thus, this renewal application now seeks to mechanistically understand how altered UPR
signaling and metabolism each contribute to AT2 reprogramming and promotion of a fibrotic niche. Leveraging
our two Sftpc mouse PF models we will first use mutant SftpcC121G as a model substrate for disruption of
proteostasis while genetically and pharmacologically interrogating UPR signaling focusing on IRE1 and ATF6
to define its impact on AT2 proteostasis, cell states, and progenitor function [Specific Aim 1]. Then using
SftpcI73T mice we will assess downstream consequences of disrupted AT2 organellar QC for metabolic
reprogramming and mitochondrial dynamics with contextualization of their impact on pathological AT2
endophenotypes and fibrotic remodeling [Specific Aim 2]. When completed deliverables produced from these
studies will enhance our understanding of the role of two understudied pathways on IPF pathogenesis and
provide equipoise and experimental platforms to catalyze discovery and testing of new IPF therapies.

Public health relevance
NARRATIVE Idiopathic Pulmonary Fibrosis (IPF) is a devastating rare lung disease of older adults marked by progressive respiratory failure for which there remains a significant unmet need for effective medical therapies. Lung epithelial cell dysfunction associated with disrupted cell quality control including an exuberant unfolded protein response (UPR)(i.e. endoplasmic reticulum (ER) stress) and/or mitochondrial dysfunction has emerged as an important causal contributor to lung fibrosis. This proposal will leverage novel mouse models expressing mutations in the Surfactant Protein C (SFTPC) gene that are associated with human lung fibrosis and will use them characterize the molecular and cellular mechanisms which contribute to epithelial cell dysfunction, emergence of pathological cell states, and the ensuing fibrotic response.